Reconstructing Somatic Chromosomes

Project Summary:
Somatic cell nuclear transfer (SCNT) replaces haploid meiotic chromosomes in metaphase (MII)-arrested
oocytes with diploid interphase chromatin from somatic cells. Such SCNT oocytes are diploid and are not suitable
for fertilization due to triploidy. However, our preliminary studies indicate that SCNT oocytes are capable of
forming premature meiotic spindles consisting of paired single-chromatid chromosomes and subsequent
activation or fertilization can induce segregation of somatic chromosomes into a pseudo polar body. Our research
will determine if somatic homolog pairing and recombination in mouse SCNT oocytes can be induced by DNA
double strand breaks and develop future therapeutic approaches for infertility treatments.

Public health relevance
Narrative: The goal of this research is to produce normal eggs from patient's skin cells to treat infertility. We will define fundamental biological questions regarding feasibility of separating chromosome pairs in diploid cells and deriving haploid oocytes.